Sequence determinants of membraneless organelle rheology

PROJECT SUMMARY/ABSTRACT
The long-term vision of my lab is to elucidate biophysical principles of mesoscale assembly in biology and to
harness those discoveries for biomedical and biotechnological advances. In that vein, the lab’s current focus is
on elucidating principles underlying intracellular phase separation. Phase separation is a fundamental process
that cells use to organize their myriad biomolecules into functional compartments, giving rise to membraneless
organelles such as stress granules, germ granules, and the nucleolus, with important roles in gene regulation,
stress response, and many additional essential functions. Conversely, aberrant phase transitions are associated
with neurodegenerative and other diseases. The overall goal of this MIRA proposal is to establish how
biomolecular sequence and composition determine the material properties of membraneless organelles, and
how material properties contribute to biological function and misfunction. We will dissect the sequence features
and molecular interactions that determine the rheology (liquid-like, solid-like, or a combination) of biomolecular
condensates formed by phase separation of intrinsically disordered proteins. We will accomplish this using
protein engineering, mutagenesis, microscopy, a suite of biophysical techniques, and nanotechnology, including
the development of a toolbox of nanoparticle probes for measuring membraneless organelle rheology. We will
then investigate how membraneless organelle rheology underlies biological function, focusing on germ granules,
and we will investigate how perturbations to membraneless organelle rheology perturb biological function.
Finally, we will examine whether certain sequence features are particularly prone to aberrant liquid-solid phase
transitions and toxicity, indicating possible origins of pathology and targets for therapies. Together, this work
seeks to provide a strong foundation for understanding the links between molecular sequence, rheology, and
function of membraneless organelles in health and disease.

Public health relevance
PROJECT NARRATIVE The material properties of subcellular structures are inextricably connected with their biological functions, just as the material properties of blood and bone underlie their distinct physiological functions. The purpose of this research is to discover what protein sequence features and molecular interactions determine the material properties of a class of intracellular compartments called membraneless organelles, which can be liquid-like, gel- like, or a combination thereof. Our vision is to understand how the material properties of membraneless organelles underlie their normal biological functions and their contributions to neurodegeneration and other disease processes.